Recruitment Core

The goal of the Recruitment core is to increase the capacity of the Morehouse School of
Medicine (MSM) U54 Center for Translational Research in Health Disparities (CTRHD) to
support translational research and the development of Multidisciplinary Translational Teams
(MDTTs) that can effectively address and eliminate health disparities in underserved
communities. To achieve this, having a strong Data Science infrastructure at MSM would be
critical. Thus, given a central goal of the CTRHD as outlined above, it has been identified that
additional in-house genomics and biomedical informatics expertise, with a translational research
background, at the faculty level is needed to enhance and maintain access to the required
informatics infrastructure to support the CTRHD. MSM is uniquely situated to address
inequalities in health and URM genomics training. MSM is one of two historically black medical
schools established in the twentieth century, with the purpose of training URM students to
become physicians, biomedical scientists, and public health professionals. Genomic research
has ushered in a new era in the science and praxis of preserving, restoring, and prolonging
human health; however, there is a paucity of diverse researchers and most of the studies to
date have focused on European ancestral populations. Genomics/multiomics research offers
tremendous challenges and opportunities for improving human health. To this end, the
Recruitment Core will pursue the following specific aims: Aim I: recruit two mid-career faculty, a
genetics/ genomics faculty and a biomedical informatician faculty to strengthen our informatics
infrastructure to support the goals of the CTRHD; Aim II: contribute to the Health disparities
research across disciplines by increasing and expanding MSM’s biomedical informatics capacity
and service in translational genomics and bioinformatics; Aim III: enhance biomedical
informatics support to basic, behavioral, and clinical researchers at MSM that will aid in the
transformation of our MSM Data Scientists; and, Aim IV: provide translational bioinformatics
support for projects, mentored research education, training and career development in minority
health and health disparities research. The proposed objectives meet MSM’s new priorities that
include becoming leaders in genomics and precision medicine, new partnerships with area
universities, local and national, to bolster education, catalyze and strengthen growth in areas of
omics, and sustainability.